Proteolytic Regulation of Factor VIII Before and After Activation

Abstract
Maintaining factor VIII (FVIII) in the normal range is critical for normal hemostasis. Deficiency of FVIII results in
the bleeding disorder hemophilia A (HA) and excess FVIII confers prothrombotic risk. While the impact of serine
protease cleavage on FVIII function has been extensively studied, the contribution of proteolysis on plasma FVIII
levels is largely unexplored. Further, we demonstrated that the significance of proteolytic inactivation of activated
FVIII (FVIIIa) has been underestimated. The overall objective of this proposal is to comprehensively investigate
the proteolytic mechanisms that govern FVIII regulation before and after activation. Factor VIII circulates in
plasma with its carrier protein von Willebrand factor (vWF). Prior to activation, FVIII levels in plasma are impacted
by endothelial stimulation (where FVIII is synthesized and stored) and binding to vWF, which regulates FVIII
clearance. We generated preliminary data in multiple model systems that support proteolysis of FVIII contributes,
in part, to plasma FVIII concentration. A major goal of this application is to understand how proteolysis of FVIII
or FVIII/vWF modulates plasma FVIII concentration, which will be investigated in Aim 1. Following activation,
downregulation of FVIIIa function occurs through spontaneous dissociation of the A2-domain and cleavage by
activated protein C (APC). Kinetic analysis suggests that A2 dissociation surpasses the rate of APC-mediated
proteolysis leading to the general conclusion that APC minimally, if at all, contributes to FVIIIa inactivation.
However, we demonstrated that a FVIII variant resistant to APC cleavage exhibits a 4-5 fold enhanced
hemostatic effect and poses a greater prothrombotic risk in vivo compared to wild-type FVIII (FVIII-WT). Thus,
our findings underscore the physiological relevance of APC inactivation of FVIIIa, challenging established
mechanistic concepts entrenched in the field. This may be partly attributed to experimental constraints of
studying FVIIIa inactivation in vitro. For example, purified system analysis of the kinetics of APC cleavage of
FVIIIa have been predominantly studied on FVIII that underestimates the rate of APC cleavage of FVIIIa or the
challenge of accurately modeling macromolecular interactions that impact FVIIIa inactivation. Another major
objective is to comprehensively elucidate the mechanism underlying the proteolytic inactivation of FVIIIa that will
be investigated in Aim 2. Our research will provide new mechanistic insight into FVIII biology, physiologic FVIIIa
regulation and inform FVIII associated prothrombotic risk. These findings will directly inform the safety and
efficacy of our and others’ work that aims to overcome current limitations of HA gene therapy limitations by using
rationally engineered gain-of-function FVIII variants that bypass mechanisms of FVIIIa regulation.

Public health relevance
PROJECT NARRATIVE The formation of a blood clot following vascular injury is an essential defensive mechanism that is highly regulated, and patients with too little or too much clotting factor VIII function have abnormal blood clotting that either results in bleeding or excess clot formation, respectively. This proposal seeks to better understand how factor VIII levels and function are regulated before and after activation. This information will inform how excess FVIII function contributes to prothrombotic risk and help to develop new and better therapies for hemophilia A, including gene therapy.